Production Assistance for Cellular Therapies (PACT) - Coordinating Center (CC)

The objective of the PACT program is to continue to advance cellular therapy research in the areas of regeneration of damaged/diseased tissues, organs, biologic systems, and targeted treatments for serious diseases without effective therapies.